Multimodal Integrative Dimension Reduction and Statistical Modeling with Applications to Temporomandibular Joint (TMJ) Morphometry and Biomechanics

Disorders associated with the temporomandibular joint (TMJ) and surrounding tissues affect 5-12% of Americans, cost $4 billion/year and, for reasons not fully known, are nearly twice as prevalent among females as
males. Despite debilitating effects of these disorders, the functional morphology and biomechanics of the TMJ
are not well understood due to its unique and complex anatomy. In particular, the biomechanics of the TMJ, how
the muscular and skeletal features interact to affect function, and quantifying sex differences in TMJ characteristics are important scientiﬁc research questions and crucial for developing safe and effective clinical treatments.
A recent, innovative study in TMJ research generated detailed data describing muscle morphometry and skeletal structure, but statistical analysis is challenging because methods do not exist that effectively integrate high
dimensional, multimodal multivariate data and target effects of intrinsic heterogeneity due to sex, age and other
factors. Such complex data now pervade craniofacial research, as computed tomography, magnetic resonance
imaging, electromyography, genotyping and other technologies jointly generate diverse information that must be
efﬁciently integrated to elucidate craniofacial development, abnormalities, and treatment strategies. There is
hence a pressing need for statistical methods that effectively integrate these high-dimensional multimodal data
and simultaneously enable discovery of features that explain heterogeneity and, therefore, can guide therapeutics. This project will develop new statistical models and dimension reduction methods to address the challenges
in the TMJ morphometry data and in multimodal data arising from dental and craniofacial studies more generally.
Three interconnected aims are: (1) Develop two new statistical models for simultaneous dimension reduction and
feature selection that will identify the linear combinations of TMJ muscle attachment and skull measurements
most differentially correlated for males and females; (2) Extend the two new models from multivariate to tensor-variate (i.e. multidimensional array data) to exploit the full structure of the 3D images and muscle attachments;
and (3) analyze the TMJ morphometry data using the newly developed statistical methods and develop and
disseminate user-friendly software. Successful completion of the proposed aims will provide new insight about
musculoskeletal associations in the TMJ and, importantly, how they vary by sex and other covariates, that can
inform future research and clinical treatment. The work will ﬁll important gaps in analysis techniques by producing a series of new statistical models, dimension reduction methods and computational tools for analyzing
conditional relationships among multimodal multivariate data, and make these methods widely available.

Public health relevance
Disorders associated with the temporomandibular joint (TMJ) affect 5-12% of Americans, incur an estimated annual cost of $4 billion and, for reasons not fully known, are nearly twice as prevalent among females as males. This project will develop new statistical models and dimension reduction methods and perform integrative analysis of existing, innovative TMJ morphology data that will advance the understanding of biomechanics and sex differences in TMJ function. The new statistical methods ﬁll important gaps in existing techniques for multivariate, multimodal data and will be widely applicable to analysis of other craniofacial and oral health data.